Earlier detection of HPV-related oropharynx cancer in people living with and without HIV

Abstract
Oral HPV is the cause of increasing incidence of HPV-related oropharynx cancer (HPV-OPC) in the
United States and globally, and is expected to continue into the next century despite an effective
vaccine. The risk of HPV-OPC and HPV-related anogenital malignancies is significantly increased
among people living with HIV (PLWH). Oral and plasma HPV and E6 antibodies are associated with
increased future risk of HPV-OPC and present an opportunity for screening for HPV-OPC. We have
developed the longest running and largest cohort of healthy people living with and without HIV, with
biomarkers of HPV-OPC. This study will combine our existing unique enriched cohort of individuals
with HPV16 biomarkers with new participants identified in a screening scenario to develop a larger
cohort of individuals at-risk for HPV16-OPC (called the MOUTH2 study). We will screen for oral and
blood biomarkers with the aim to 1) study progression to HPV-OPC and how it differs in those with
and without HIV; 2) characterize impact of HIV on oral HPV16 persistence, and 3) evaluate
performance characteristics of stand-alone vs sequential biomarker screening. This prospective
observational cohort will provide the ability to examine questions necessary to understand the long-
term natural history of oral HPV in people living with and without HPV and to inform future study
design to elucidate the benefits and harms of screening.

Public health relevance
Narrative This project has the potential to identify, for the first time, a screening strategy for earlier detection of HPV-related oropharynx cancer in people living with HIV and without HIV, and to outline a screening algorithm for HPV-OPC that could be tested in a future clinical trial to determine efficacy.